Cardiopulmonary Risk Assessment from Smoke Exposure at the Wildland Urban Interface

PROJECT SUMMARY
Acute and chronic wildland fire smoke inhalation have been linked to increased mortality as well as respiratory
and cardiovascular morbidity, though the extent to which the frequency and duration of exposure or the
chemical and particle profiles of the smoke contribute to the observed health effects remains unknown. As the
occurrences of wildland fires and number of people living at the wildland urban interface (WUI) continue to
increase, prolonged inhalation of wildland fire smoke poses a serious threat to public health. Due to this, there
is an urgent need to better understand the adverse cardiopulmonary outcomes associated with the exposure to
wildland urban smoke. The smoke that arises from wildland fires at the WUI is a complex mixture of gases,
trace metals, and fine and ultrafine particles. The latter are particularly dangerous for human health, since they
deposit in the deep regions of the lungs and may translocate into the blood stream, increasing the oxidative and
inflammatory burden, both locally and systemically. Prolonged inflammation can lead to the development of
obstructive lung disease and atherosclerosis. To investigate the link between exposure to WUI smoke and
development of cardiopulmonary dysfunction, our interdisciplinary team brings together expertise in fire
generation and characterization, rodent aerosol exposures, respiratory mechanics, lung biology, and
cardiovascular physiology. To fulfill our goals, we will create lab-scale smoke using materials representative of
WUI regions in Southern California and we will deliver it to mice. In Aim 1, we will investigate the role of
frequency and duration of the exposure, as well as particulate concentration of the wildland fire smoke. In Aim
2, we will focus on the relative contribution of different fuel sources characteristic of the WUI. Furthermore, as
part of this ONES early-stage-investigator project, the PI and co-Is will generate an external advisory panel
consisting of inhalation toxicology researchers, public health advocates, and fire protection experts.
Dissemination of new knowledge gained from this proposal to the community will be a vital part of this
endeavor.

Public health relevance
PROJECT NARRATIVE Wildland fire smoke inhalation has been linked to disease of the cardiopulmonary system, but the contribution of exposure frequency and duration, as well as smoke composition remain unknown. With the occurrence and severity of wildland fires on the rise, there is an urgent need to understand the negative health consequences of smoke inhalation, in order to properly inform and protect at risk populations. In this proposal, we evaluate changes in the cardiopulmonary function of adult mice after prolonged fire smoke inhalation, modeling conditions at wildland urban interface regions.